KanSurvive 2.0

Project Summary/Abstract
Cancer survivors require long-term and coordinated care to address the physical, emotional, and psychosocial
effects of cancer and its treatment. Rural cancer survivors are disproportionately affected by chronic illness
and face a higher risk of negative health outcomes. Primary care providers (PCPs) recognize the importance of
delivering evidence-based practice (EBP) cancer survivorship care and are well-positioned to provide
comprehensive and coordinated care, however, the needs of cancer survivors are frequently unmet, and
providersdescribe limitations in knowledge of risk-based surveillance, long-term effects of cancer treatment
and their management, inadequate resources, and growing administrative demands as barriers to improving
survivorship care. The overall goal of this project is to test the effectiveness of pragmatic strategies to promote
high quality, evidence-based guideline concordant care for rural adult cancer survivors in primary care practice
utilizing tools from implementation science to gain a better understanding of the decision making and actions
taken that facilitate or hinder implementation across multiple healthcare systems. To achieve this objective, we
propose a three-arm cluster-randomized, multi-level intervention to provide education, tele-mentoring, and
whether 1) virtual scribes filling the role as trained medical assistants, 2) a team-based approach, 3) or usual
care produces more guideline concordant cancer survivorship care. The primary outcome is practice level
completion and documentation of cancer survivorship care as measured using a previously developed
composite scoring system that compares electronic health record (EHR) documented activity to National
Comprehensive Cancer Network survivorship guidelines. The secondary outcome is to assess intervention
sustainability of arm 1 and 2 activities at 12 and 24-months post implementation; measured as a function of
virtual scribe or team-based care actions to promote prior cancer diagnoses coding (ICD-10), use of EHR tools
and health maintenance order sets and annual ordering of appropriate screenings for cancer survivors. Prior to
implementation, formative evaluations will assess current systems of care and practice-level barriers and
facilitators for the delivery of EBP cancer survivorship care and inform modifications to implementation
Guided by the Normalization Process Theory, we will examine agentic factors (e.g., actions
taken/decisions made by the practice) to modify modes of care management and delivery. The RE-AIM
evaluation framework will be used to explore potential population-level impact and generalizability of the
intervention in real-world clinical settings.
strategies.
The study will be conducted in 16 rural primary care practices in
Kansas and was intentionally designed to bring care delivery changes into resource-limited practices and
health systems. Results will add new evidence by informing pragmatic strategies to facilitate the adoption and
delivery of EBP cancer survivorship in rural primary care.

Public health relevance
Project Narrative Rural cancer survivors experience a higher risk of negative health outcomes and require coordinated care to address the many effects of cancer and its treatment. Primary care providers recognize the importance of providing high-quality, evidence-based survivorship care and are well-positioned to meet survivor needs, however, these needs are often unmet due to limitations in knowledge, lack of resources, and administrative demands. Practical strategies are needed to assist PCPs to improve cancer survivorship care and this proposal will test implementation strategies to optimize the adoption of evidence-based practices for cancer survivorship care in rural primary care settings.